Balancing Act: Equalizing Sex Specific Differences in CENP-A levels is Critical for Mammalian Embryogenesis

PROJECT SUMMARY
Abnormal chromosome numbers (aneuploidy) are common in early embryos, particularly mammals. Embryonic
aneuploidies can arise during gamete differentiation (inherited) or during mitotic divisions in the embryo
(acquired). While previous studies have primarily focused understanding how inherited aneuploidies occur, the
molecular origins of acquired aneuploidies are not well understood. Substantial literature has implicated
specialized regions of chromosomes, termed centromeres, as critical for mediating proper chromosome
segregation during cell division. Centromeres are epigenetically defined by the presence of nucleosomes
containing the histone H3 variant CENP-A. Work conducted in somatic model systems has demonstrated that
the quantitative maintenance of CENP-A nucleosomes at centromeres is essential for faithful chromosome
segregation. Thus, somatic CENP-A levels are quite stable. However, our lab and others have shown that CENP-
A is highly dynamic in the germline, and is regulated in a sex-specific manner, resulting in the generation of
terminally differentiated gametes (sperm and MII oocytes) with drastically different levels of CENP-A. Despite
this drastic difference in CENP-A levels, we have shown that parental CENP-A levels approximately equalize in
the zygote, prior to entry into the first mitosis. The overarching objective of this proposal is to investigate how
CENP-A levels between maternal and paternal centromeres equalize during the first cell cycle. Our preliminary
data indicates that maternally inherited CENP-A protein is deposited onto paternal centromeres. Additionally,
analysis of early post-fertilization stage zygotes indicates that CENP-A deposition machinery is preferentially
recruited to paternal centromeres. Furthermore, earlier literature has revealed that chromatin remodeling is
differentially regulated between the maternal and paternal genomes. Thus, my central hypothesis is that CENP-
A equalization is essential for proper early embryonic development and is controlled by centromeric and
pericentromeric chromatin factors that differ between the two parental genomes, leading to asymmetric
deposition of CENP-A prior to gametic nuclear fusion. In Aim 1 I will define the source of CENP-A protein used
during zygotic equalization. For Aim 2, I will determine the chromatin factors involved in regulating CENP-A
zygotic equalization. Finally, in Aim 3 I will test the control mechanism for zygotic CENP-A levels. Completion of
this project will contribute knowledge to how zygotic CENP-A regulation mediates proper chromosome
segregation in early mammalian embryos.

Public health relevance
PROJECT NARRATIVE Chromosomal abnormalities (i.e., aneuploidy) in oocytes and embryos are a major cause of infertility and recurrent pregnancy loss, with about 30-80% of embryos derived in IVF clinics being aneuploid. While it has been known that chromosome segregation errors occur during female meiosis, recent findings reveal that an increasing number of aneuploidies originate during mitotic divisions in the embryo, affecting only subsets of cells, and contribute to embryo mosaicism. Thus, this project proposes and tests the role of maternally inherited CENP-A in regulating early mammalian embryo development and preventing mosaicism.